Modeling and Characterizing the Genomic Consequences of MED12 Mutations in Uterine Fibroids

ABSTRACT
Uterine fibroids (leiomyomas) are the most widely observed tumors in women. By age 50, more than ~70% of
white and more than 80% of black women develop at least one UF tumor. Although non-malignant, they disrupt
normal uterine function and cause severe health problems ~25% of reproductive-age women. The most common
subtype, representing ~70% of all fibroids, is caused by recurrent somatic mutations in the MED12 gene that
encodes the mediator of transcription subunit 12 (MED12) protein. The lack of proper model systems hampered
our mechanistic understanding of UF development and identifying effective treatment strategies. Our long-term
goal is to interrogate the functional role of driver genetic mutations in fibroid tumors and identify potential
targetable mechanisms downstream of these mutations. Our objective in this proposal, a critical step toward our
long-term goal, is to create and exploit disease-relevant human cellular models of UF by CRISPR engineering
specific MED12 mutations, decipher their functional role in driving UF tumorigenesis and identify druggable
mechanisms to target mutant cells selectively.

Public health relevance
NARRATIVE Uterine fibroids (UF), also called leiomyomas, are the most widely observed tumors in women and the large majority of UFs (>70 %) are caused by recurrent genetic mutations in a gene called MED12. The lack of proper model systems hampered our mechanistic understanding of how these mutations cause UF tumorigenesis and identifying druggable targets. This proposal aims to create disease-relevant human cellular models through CRISPR engineering specific MED12 mutations to decipher the functional role of MED12 mutations and identify druggable mechanisms to target mutant cells selectively in UF.